Mechanisms of inflammation-triggered taste loss and its recovery

PROJECT SUMMARY
Taste loss can lead to malnutrition, weight loss, and depression. In addition, changes in taste are a symptom of
poor health. This cyclical relationship between taste and health highlights the importance of research aimed at
understanding taste loss in both health and disease. Research on taste loss will provide new approaches in the
prevention, diagnosis, and treatment of disease. It is well-documented that infections and autoimmune
conditions are accompanied by changes in chemosensory perception including changes in taste. However,
currently we know little about how taste bud regeneration is regulated, and there is no effective treatment for
taste loss. Our recent research indicates that inflammation, characterized by induction of inflammatory
cytokines and infiltration and activation of immune cells, contributes significantly to taste dysfunction. We
hypothesize that inflammation, particularly through the action of the inflammatory cytokine interferon-γ (IFN-γ),
contributes to taste loss by inducing cell death and inhibiting taste bud cell renewal, and that resolution of
inflammation promotes taste bud regeneration. IFN-γ can be produced by various types of immune and
nonimmune cells in response to infections and autoimmunity. Its levels in taste tissues are markedly increased
in an autoimmune disease model with taste loss. Yet, whether IFN-γ directly contributes to taste loss has not
been determined. In this project, we propose to investigate the role of inflammation, especially IFN-γ, in taste
loss using both a transgenic approach and a clinically relevant respiratory viral infection model. We will then
use these taste loss models to study the mechanisms of taste bud regeneration. This research will test
mechanistic hypotheses of how inflammation and infection cause taste loss, and how taste responses recover.
To underscore the importance of research investigating the link between inflammation, disease, and taste loss,
a considerable number of COVID-19 patients experience taste dysfunction. Although most cases of taste loss
are temporary, including taste loss associated with SARS-CoV-2 infection, long-term taste loss can occur in
some patients. Thus, insights from this research will be informative to better understand taste loss in general,
as well as taste loss associated with COVID-19.

Public health relevance
PUBLIC HEALTH RELEVANCE Taste loss contributes to malnutrition, depression, and reduced quality of life in affected patients. In this project, we will investigate the role of inflammation in taste loss using both a transgenic approach and a respiratory viral infection model. Our goal is to characterize the relationship between inflammation, taste loss, and taste bud regeneration to provide mechanistic insights for future therapies aimed at correcting or preventing immune-related taste dysfunction.